Treating Tumoral Hypoxia via Ultrasound-Guided Oxygen Release for Improving Radiation Therapy

PROJECT SUMMARY
Cancer affects 39.6% of Americans at some point during their lifetime. Solid tumor microenvironments are
characterized by a disorganized, leaky vasculature that promotes regions of low oxygenation. In fact, tumor
hypoxia is a key predictor of poor treatment outcome for all radiotherapy, chemotherapy and surgery procedures,
as well as a hallmark of metastatic potential. In particular, tumor cell resistance to radiotherapy is 3 fold increased
in anoxic cells and even very small tumors comprise 10-30% of hypoxic regions in the form of chronic and/or
transient hypoxia fluctuating over course of seconds to days. Recently, lipid-stabilized oxygen microbubbles
(OMBs) have been used in vivo to relieve tumor hypoxia in sonodynamic therapy when injected directly in the
tumors, as well as shown to sustain asphyxiated animals for over two hours when injected intra-peritoneally. Our
preliminary data supports our hypothesis that oxygen microbubbles could also be used to relieve tumor hypoxia
during radiotherapy and significantly improve treatment outcome. In addition, there has been no systemic OMB
delivery demonstration to date for tumor hypoxia modulation with OMBs, due in part to the difficulty of measuring
hypoxia in vivo reliably in combination with these administrations. We hypothesize that we can guide specially
formulated OMBs via ultrasound imaging, and preferentially release oxygen, in the tumor for radiosensitization
to significantly improve the radiotherapy therapeutic ratio. In order to test our hypothesis, will optimize
microbubble formulations and administration parameters, evaluate biological mechanisms and kinetics, and
validate our hypothesis both in a rodent model and then in a translational large animal model across two of the
leading veterinary schools in the country. To achieve these goals, we approach this project with a collaborative
team of leading experts in the fields of microbubbles, oxygen transport, radiation oncology, and tumor biology.

Public health relevance
RELEVANCE TO PUBLIC HEALTH It is well known that cancer is resistant to radiation therapy in part due to the lack of oxygen present in the tumor environment. In this project, we propose to use intravenously administered biocompatible microbubbles loaded with oxygen, which can be released into the tumor tissue to make cancer cells more susceptible to radiation therapy. We will develop and optimize this approach as a translatable technology and then test it in patient dogs (pet dogs that are brought into the veterinary hospital with cancer) to test if it works effectively, with the long- term goal for translation into humans.